An Information tecHnology approach to implEmenting depression treAtment in caRdiac patienTs: [iHeart Trial]

The goal of this proposal is to test whether a theory-informed multicomponent intervention involving an
electronic shared decision making (eSDM) tool (iHeart Trial) can increase the uptake of depression treatment
following acute coronary syndromes (post-ACS). Depression is three times more common in depressed post-
ACS patients than the general population and doubles the risk of recurrent cardiac events and mortality.
Depression treatment can improve debilitating depressive symptoms and quality of life. Multiple scientific
groups recommend screening for depression and treating when indicated in post-ACS patients. Despite
decades of observational data and expert guidelines, only 30% of depressed post-ACS patients receive
treatment, far lower than the treatment rates seen in the general depression population.
This proposal is a culmination of years of work with multiple study sites, innumerable patients, IT personnel
and experts in depression and cardiovascular disease. We reviewed systematically all interventions targeting
depression treatment engagement in primary care settings. We conducted a nationwide survey of 352
depressed post-ACS patients. We ran behavioral and primary care provider focus groups to ascertain barriers
to depression treatment in primary care in 8 healthcare systems that had implemented depression screening
and treatment. We learned that key barriers to depression treatment are (1) suboptimal rates of depression
recognition and referral by providers and (2) dismissal of the importance of depressive symptoms and lack of
ability to choose type of depression treatment by patients. Using these formative data, we applied a theory-
informed process of engaging stakeholders to select an acceptable, feasible intervention and determined that
eSDM would target the greatest number of barriers to implementing patient preferred depression treatment in
post-ACS patients. We subsequently developed and alpha tested an iPad delivered, video-assisted,
interactive eSDM tool that aims to reduce barriers to depression treatment in cardiac patients.
We hypothesize that this state-of-the-art, theory-driven eSDM tool that automates the SDM process,
activates providers, staff, and patients and interfaces with the electronic health record will improve
implementation of depression guidelines in post-ACS patients with persistently elevated depressive symptoms.
We propose to conduct a stepped wedge trial across 8 primary care clinics to assess the effectiveness of our
eSDM tool on depressive symptoms (primary outcome) and depression treatment uptake (Aim 1) and
implementation processes such as depression screening and treatment referral (Aim 2). Key outcomes will be
rigorously assessed amongst 368 depressed post-ACS patients. Our study has the potential to produce a
theory-informed, scalable eSDM tool that improves the implementation of post-ACS depression guidelines.

Public health relevance
Even though multiple expert guidelines recommend depression screening and treatment following acute coronary syndrome (ACS), only 30% of depressed post-ACS patients receive depression treatment. Key barriers include suboptimal depression recognition/referral rates by providers and low engagement in treatment by patients. We propose a stepped wedge trial across 8 primary care clinics to test the effectiveness of a scalable, theory-driven electronic shared decision making tool that is designed to increase depression recognition and treatment engagement, and ultimately, improve depressive symptoms in post-ACS patients.